Community Outreach and Engagement

Vanderbilt-Ingram Cancer Center (VICC) is located in a region with some of the highest cancer incidence and mortality rates in the US. As the only NCI-designated Comprehensive Cancer Center serving both adult and pediatric populations in Tennessee (TN), VICC encompasses a geographically wide catchment area of 123 counties across TN, western Kentucky (KY), and northern Alabama (AL) from which 90% of VICC cancer patients currently are drawn. Seventy of the 123 counties (57%) are classified as rural, in which 25% of the catchment area population lives. VICC Community Outreach and Engagement (COE), under the leadership of Associate Director Karen Winkfield, MD, PhD (CO), integrates with VICC Research Programs and administrative initiatives to reduce the cancer burden within the catchment area and beyond. In a bi-directional manner, leveraging relationships with patients and community stakeholders, COE obtains input from the community on priorities for research, cancer control and care and works with VICC research programs and community partners to bring those prioritized initiatives out to the community. The specific aims of COE are to: 1) Assess and prioritize cancer-related needs and opportunities in the catchment area; 2) Inform and facilitate programmatic research that is responsive to identified cancer-related needs and community-driven priorities; and 3) Promote the implementation and dissemination of evidence-based cancer prevention, control and care. Community-driven priorities identified through COE include cancer prevention initiatives, improved access to care through technology, holistic treatment and support, implementation of evidence-based practice and policy, advancing discoveries, and research advocacy. VICC conducts basic, clinical and population science research that addresses catchment area needs and aligns with these community-driven priorities. COE staff collaborate with partners to meet evolving community-identified needs through a variety of collaborative community outreach activities. Working together with partners and stakeholders, VICC community-informed research and cancer control activities synergistically contribute to empowering healthy and cancer literate communities in our catchment area and beyond. The impact of these efforts is already evident in improved practices at Vanderbilt University Medical Center (VUMC) and affiliated sites, including newly available tobacco screening/counseling, enhanced patient navigation, expanded reach of lung cancer screening and improved adherence to breast, colorectal and cervical cancer screening guidelines, HPV vaccination and inherited cancer screening. Moving forward, focus will be placed on metrics of increased accruals to research studies; improvements in cancer-related knowledge, attitudes and behavior; and expanded implementation of evidence-based guidelines and health policies. Together with community partners, VICC positively impacts the catchment area by enabling a systems approach to cancer, advancing fundamental research and translating discoveries from the bench to the clinic, community and population in the catchment area, nationally, and globally.

Public health relevance
Vanderbilt-Ingram Cancer Center (VICC) is located in a region with some of the highest cancer incidence and mortality rates in the US. VICC has a geographically wide catchment area of 123 counties across TN, western Kentucky (KY), and northern Alabama (AL) from which 90% of VICC cancer patients currently are drawn. Seventy of the 123 counties (57%) are classified as rural, where 25% of the catchment area population lives. Demographic characteristics vary substantially within the catchment area. VICC has a long tradition of engaging community partners in research and outreach initiatives in our catchment area. Under the leadership of Karen Winkfield, MD, PhD (CO), Associate Director for Community Outreach and Engagement (COE), COE integrates with VICC administrative and research initiatives to address the VICC mission to reduce the cancer burden in the catchment area and beyond. COE uses a bi-directional model of community engagement, and in collaboration with investigators, patients and community stakeholders, the specific aims of COE are to: 1. Assess and prioritize cancer-related needs and opportunities in the VICC catchment area 2. Inform and facilitate programmatic research that is responsive to identified cancer-related needs and community-driven priorities 3. Promote the implementation and dissemination of evidence-based cancer prevention, control and care The VICC catchment area is notable for a disproportionate burden of cancers of the lung, colon/rectum, cervix, oropharynx, pancreas, esophagus and melanoma of the skin. HPV- and obesity-related cancers are common, coupled with low HPV vaccination rates and a high prevalence of obesity. Community-identified catchment area needs include access to cancer education, prevention, early detection and care, as well as support for patients and caregivers. Based on these needs, our patients and community stakeholders have identified priorities that focus on cancer prevention, improved access to care through technology, holistic treatment and support, evidence-based practice and policy, advancing discoveries, and research advocacy. These catchment area needs and community-driven priorities have and will continue to inform the design and conduct of basic, clinical and population science research conducted by VICC investigators. Such research will lead to the development, dissemination and implementation of evidence-based practices, as well as influence health policy, with the potential for meaningful impact on population-level outcomes. Working with our patients, advisory boards, community partners and stakeholders, we have brought research, education and advocacy centered on topics that include: 1) smoking cessation, 2) lung cancer screening, 3) obesity prevention and interventions, 4) promotion of HPV vaccine, 5) genetic counseling and testing, 6) remote access to molecular tumor boards, 7) clinical trials and 8) survivorship care to our catchment area and beyond, with a focus on decreasing the burden of cancer. Moving forward, COE will improve access to clinical research and guideline-based cancer care throughout our catchment area. This will be done through expanding our Research Advocacy Program (RAP), using patient-focused technology to assess barriers to recruitment and retention in clinical trials, and building a research network within the catchment area. We will leverage partnerships to address challenges in HPV vaccination, tobacco cessation and cancer screening within healthcare settings and expand community education to new populations. We will also increase capacity and use of community engagement strategies in research among VICC investigators and enhance community interactions with all research programs. Working together with partners and stakeholders, VICC community-informed research and cancer control activities synergistically contribute to empowering healthy and cancer literate communities in the VICC catchment area and beyond. The impact of these efforts is already evident with respect to improved adherence to guidelines for prevention and screening. Moving forward, focus will be placed on metrics of 1) increased accruals to research studies; 2) improvements in cancer-related knowledge, attitudes and behavior; and 3) expanded adoption and implementation of evidence-based guidelines and health policies. Incorporating the VICC Strategic Directions of reducing the cancer burden, enabling a systems approach to advance fundamental discoveries and translate discoveries to therapeutics, we can improve the health and wellbeing of those in our catchment area and beyond. The education, research and advocacy conducted by VICC have been and will continue to be advanced by bi-directional input from and outreach to our community. This is and will remain the central tenant of VICC COE.